Defining Novel Molecular Pathways to Totipotency

PROJECT SUMMARY
Totipotency, a remarkable cellular plasticity of a single cell in generating a complete organism with both
embryonic and extraembryonic contribution, is essential for multicellularity and development. In mice, fully
totipotent cells exist transiently in the zygote and cleavage-stage blastomeres, although totipotent 2-cell (2C)-
like cells (2CLCs) can also arise sporadically or induced genetically in cultured embryonic stem cell (ESCs)
that are pluripotent and can only contribute to embryonic lineages. Recently, expanded potential stem cells and
extended pluripotent stem cells, collectively known as EPSCs, with totipotency features were derived and
stably cultured in vitro using two distinct sets of small molecule inhibitors. However, 2CLCs and the two EPSC
lines differ in their culture conditions, transcriptomes, and expression of core pluripotency factors, suggestive of
alternative totipotent states. 2CLCs and EPSCs represent easily accessible cell source and valuable in vitro
models for understanding totipotency, the knowledge of which will be critical to capture and stabilize the
totipotent 2CLC state, which is not currently possible. Defining molecular pathways underlying these various
totipotent cells will facilitate unraveling the complex regulatory mechanisms of totipotency and achieving the
capture/stabilization of totipotent 2CLCs. The totipotent 2CLCs were reported to reactivate transcription of
endogenous retroviruses (ERVs), in particular MERVL, whose activation has now been found to be causative
for totipotency in our preliminary studies. ZSCAN4 is also sharply expressed in 2C-stage embryo and marks
those sporadic ESCs exiting from the ESC state towards 2CLCs. By characterizing MERVL/ZSCAN4 double
reporter positive (DR+/+) ESCs, we have begun to dissect the molecular pathways underlying 2CLC
totipotency and discovered miR-344 and its direct target ZMYM2 as novel positive and negative regulators,
respectively, for MERVL activation and 2CLC totipotency. The objective of this application is to extend our
knowledge of the divergent cellular potency states in ESC culture, and define the MERVL contribution to
totipotency and explore transcriptional and post-transcriptional mechanisms underlying totipotency. We
hypothesize that 2CLCs represent an alternative totipotent state that is regulated by a novel molecular axis
encompassing the transcriptional and post-transcriptional mechanisms. We propose the following studies to
test our hypothesis. 1) Define a molecular roadmap for alternative totipotent states in EPSCs and 2CLCs. 2)
Establish the functional contribution of MERVL elements to 2CLC totipotency. We will define and distinguish
functional roles of individual MERVL elements in contributing to 2CLC totipotency. 3) Dissect the molecular
mechanism underlying 2CLC totipotency by establishing miR-344 as a new paradigm for understanding
mammalian totipotency. Understanding the molecular mechanisms that drive and induce totipotent features in
vitro is essential to understanding of how a maximum degree of cellular plasticity can be achieved and
maintained, thereby providing more options for efficient reprogramming and potential therapeutic avenues.

Public health relevance
PROJECT NARRATIVE Understanding the molecular mechanisms that induce totipotent features in vitro is essential to understand how a maximum degree of cellular plasticity can be achieved and maintained in culture. The ability to isolate and culture totipotent cells capable of giving rise to the entire conceptus would enhance our capacity to study early embryo development, provide more options for efficient reprogramming, and enable more efficient generation of chimeric animals for research and organ production in transplantation therapy.